HEPATIC GLUCOSE METABOLISM IN SHOCK

DESCRIPTION: (Adapted from the applicant's abstract) Altered glucose regulation is a key feature of metabolic dysfunction in sepsis and shock. Previous studies by the investigator and others have shown that altered hepatic receptor signaling plays an important role in hepatic glucose metabolic dysfunction in shock. The primary goal of the proposed research is to investigate molecular mechanisms responsible for changes in the adrenergic G protein effector pathways in rat liver during the early "hypermetabolic" and late "hypometabolic" phases of sepsis. The specific objectives include: 1) studies of transcriptional and translational mechanisms for the externalization and internalization of adrenergic receptors in rat liver during the early and late phase of sepsis; 2) characterization of the transcriptional and translational modifications of Gas, Gai, Gq, and the B subunit of the G proteins in rat livers in the two septic phases;and 3) the investigation of responses mediated by the G proteins (Gas, Gai, Gq and the B units), i.e., activities of the enzymes, adenylate cyclase, phospholipase C, D, and A2 and their relationships to its activation during early and late sepsis.